INTEGRATION OF HORMONAL SIGNALS IN HYPOGLYCEMIA

To evaluate whether counter regulatory hormone response during exercise is pulsatile. Blood glucose concentratins are quite stable during exercise, but in spite of this, the hormonal response is hypothesized to be pulsatile.